The Trinucleotide Repeat Containing 6a-Mediated miRNA Activities in the Ciliogenesis of Airway Epithelium

? DESCRIPTION (provided by applicant): Tnrc6a proteins are essential for miRNA-mediated gene silencing, a fundamental mechanism required for proper development, homeostasis, and function of an organism. The function and mechanism of Tnrc6a (GW182) and its associated cytoplasmic granules, GW/P-bodies (GWBs) have been well studied in mammalian cells cultured in vitro. However, the significance for the formation of GWBs is unclear. Moreover, the expression, localization and function of Tnrc6a and GWBs during development in vivo are still poorly understood. To study Tnrc6a and GWBs in vivo, we have generated Tnrc6a mutant mice, and shown that Tnrc6a is required for miRNA-induced gene silencing. In this proposal, we will expand our studies to understand a subcellular localized miRNA mechanism that is associated with Tnrc6a and GWBs in multiciliated cells of airways. We have remarkable preliminary observations that Tnrc6a is highly expressed in multiciliated cells and Tnrc6a proteins are concentrated in GWBs that are closely associated with centrioles/basal bodies. Moreover, disruption of Tnrc6a expression leads to major defects in cilia formation. In Aim1, we proposed to determine how Tnrc6a regulates cilia formation and function by affecting key cellular events of ciliogenesis. In Aim 2, we proposed to rigorously characterize these unique multiciliated cell-specific GWBs, and determine the functional significance of formation and localization of Trnc6a/GWBs in ciliogenesis. In Aim3, we will identify the miRNA program associated with these centriole associated GWBs that regulates ciliogenesis. Successful accomplishment of these studies will allow us to identify a novel subcellular localized miRNA mechanism in ciliogenesis that is associated with selectively enriched expression of Tnrc6a and the formation and localization of GWBs. RELEVANCE TO PUBLIC HEALTH: Aberrant expression and function of miRNA activities have been associated with human disorders including primary ciliary dyskinesia (PCD). Studies proposed in this application are aimed to elucidate novel and fundamental miRNA mechanisms that are essential for proper differentiation of multiciliated cells. Results from these studies should provide insight into how miRNAs regulate normal cilia assembly during development and how deregulation of this process leads to defective cilia in human disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: miRNAs have been demonstrated to play a critical role in cilia formation. Disruption of miRNA expression leads to short and sparser cilia, which is associated with coughing and bronchitis, a common outcome of Primary Ciliary Dyskinesia (PCD). However, the underlying mechanism of miRNA action is still poorly understood. This proposal focuses on the specific role of theTnrc6a-mediated miRNA mechanism in the ciliogenesis of airway epithelial cells. Novel knowledge generated from these proposed studies will significantly advance our understanding of how proper ciliogenesis is regulated and how deregulation of this pathway leads to human disorders.